Engineering a human neuroimmune specific viral vector from Zika virus

PROJECT SUMMARY
Inflammation has been implicated in nearly every neuropsychiatric and degenerative disease,
yet neuroimmune cells remain nearly intractable by every available therapeutic strategy. Small
molecule drugs consistently fail clinical trials, as neuroimmune signaling pathways have essential
pleiotropic functions in neighboring cell types. Meanwhile cell type selective therapies remain elusive,
as microglia, and other neuroimmune cells, are intrinsically resistant to gene therapy vectors.
Overcoming these unique challenges demands a new approach to medicine, drawing from an unlikely
source of neuroimmune specific bioactivity.
In nature, the Zika virus (ZKV) infects microglia, suppresses inflammation, and stimulates
autophagy so expertly that almost half of infections go unnoticed. If this bioactivity could be safely
refined, it would offer relief for neurodegenerative disorders from Parkinson’s to Alzheimer's disease.
Parsing therapeutic from pathogenic mechanisms of the ZKV genome presents much greater
complexity than ever previously addressed, but recent advances make it possible. Recombinant ZKV
vectors, already in use, provide starting material for synthetic biology, while new viral assisted and
continuous evolution methods allow bioengineering at scales capable of reshaping whole genomes.
We can harness ZKV’s microglia specific immunosuppressive mechanisms into therapies with
potential beyond any current technology. This proposal presents the first steps along the path
towards an entirely new kind of therapy for neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE: Viruses have been engineered into invaluable tools for research and vehicles for therapeutics, but none effectively reach neuroimmune cells. The Zika virus offers a host of mechanisms to selectively target and suppress the intrinsic and innate immune responses of microglia, the predominant immune cell. We propose the domestication of Zika into a neuroimmune selective vector and a platform for tailored immunomodulation. The bioactivity can be harnessed into root cause therapies for the treatment of neuroinflammatory and degenerative diseases.